ANTIVIRAL DRUG KINETICS IN VITREOUS USING MICRODIALYSIS

DESCRIPTION (adapted from Abstract): The broad, long-term objective of the proposed research is to develop a rational intravitreal and systemic drug delivery strategy for treatment of cytomegalovirus (CMV) and herpes simplex virus (HSV) infections. In order to accomplish this, the Principal Investigator has employed microdialysis to sample continuously the vitreous compartment in order to obtain detailed pharmacokinetic information. Preliminary information from the experiments conducted by the Investigator indicates the half-life of ganciclovir in the vitreous is two hours in albino rabbits whereas it is 6 hours in pigmented rabbits. The pigmented rabbit will be used for the proposed study. The microdialysis technique and half-life findings form a basis for the development of controlled long-term intravitreal delivery systems for treatment of infections such as CMV retinitis. This project will attempt to prolong the therapeutic levels of acyclovir and ganciclovir from intravitreal injection by entrapping the drug into biodegradable and biocompatible microspheres. Additional specific aims of this project are to elucidate the dose, Na, K ATPase and metabolic energy dependence, if any, of the vitreous elimination kinetics of purine antiviral analogs.